CORE--DATA MANAGEMENT AND STATISTICS

The Data Management and Statistics Core will be created, incorporating the previous Data Management and Analysis Component of the Administrative Core. The role of this Core will be to facilitate research through the University of Pittsburgh Alzheimer's Disease Research Center by providing high quality data and methodological support. Specifically, the aims of this newly created Core will be: 1. Provide efficient data collection and entry systems to ensure complete and accurate data 2. Collaborate with NACC and NIA initiatives to contribute to national databases 3. Enable ADRC investigators to obtain data as privilege permits 4. Provide data and methodological and analytical support to authorized ADRC researchers